TR&D 4: Revealing Microstructure: Biophysical modeling and validation for discovery and clinical care

TRD4 Project Summary
The broad mission of our Center for Advanced Imaging Innovation and Research (CAI2R) is to bring
together collaborative translational research teams for the development of high-impact biomedical imaging
technologies, with the ultimate goal of changing day-to-day clinical practice. With the other three Technology
Research and development (TR&D) Projects in our Center focused on generating rich, quantitative data
streams, a key question remains: What do these data streams really mean at the level of tissue function?
Answering such a question requires bridging spatial scales from the macroscopic (millimeter) dimensions of
image voxels to the mesoscopic (micrometer) dimensions of cells, where many disease processes originate.
An ability to map cellular-level biophysical parameters would open new productive avenues for both clinical
applications and basic research. In TR&D Project 4, we will integrate tissue microstructure mapping into
comprehensive image acquisitions, to achieve specificity to tissue changes at the cellular level, for
understanding physiology and pathology, for earliest disease detection, for monitoring of disease progression,
and for quantification of treatment efficacy. The overarching goal of this project is to transform MRI from an
imaging device to an accurate and precise scientific instrument for measuring microstructural tissue
parameters. Our Specific Aims are 1) To establish the underlying biophysical information content of MRI data,
using methods from mesoscopic physics; 2) To develop and validate biophysical models for the microstructure
of brain, muscle, and cancer tissues, which may be used to convert image data to microstructural maps in
patients with neurological, musculoskeletal, or oncologic disorders; and 3) To translate these modeling and
mapping approaches into clinical practice.